Task A77: Xenograft mouse models for varicella zoster virus and human cytomegalovirus

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.